Deciphering the Mechanisms by which Long Chain Fatty Acid Oxidation Influences Spatial Microvesicular Steatosis

PROJECT SUMMARY
Metabolic dysfunction-associated steatotic liver disease (MASLD) is associated with a 4-year decrease in
lifespan and is expected to become the leading cause of liver related morbidity and mortality within the next 15
years. A hallmark of MASLD is the accumulation of small (microvesicular steatosis) and large (macrovesicular
steatosis) lipid droplets in the liver. However, mechanisms driving the size and zonal deposition (e.g.
accumulation in periportal versus pericentral hepatocytes) of lipid droplets remains poorly understood. The
carnitine palmitoyltransferase 1a (Cpt1a) enzyme facilitates long chain fatty acid oxidation, but impairments in
this pathway have been associated with microvesicular steatosis and reductions in circulating polyunsaturated
fatty acids (PUFAs) in humans. Therefore, this proposal aims to identify the mechanisms explaining these
associations. Using a mouse model of impaired long chain fatty acid oxidation, preliminary data shows a sexually
dimorphic response to liver-specific deletion of Cpt1a characterized by panlobular microvesicular steatosis in
female mice while only slight periportal steatosis in male mice. In addition, female knockout mice develop
exacerbated inflammation which coincides with reductions in ω3-PUFAs in the liver. Therefore, Aim 1 utilizes in-
vitro mechanistic approaches to quantify lipid droplet dynamics and peroxisomal oxidation of PUFAs in response
to Cpt1a-deletion in cultured hepatocytes. Aim 2 utilizes gain- and loss-of-function approaches to modulate
Cpt1a expression specifically in periportal and pericentral hepatocytes across male and female mice. To assess
the impact of zonal-specific Cpt1a deletion and overexpression on the progression from MASLD to metabolic
dysfunction-associated steatohepatitis (MASH), livers will be used for dual spatial transcriptomics and lipidomics,
and for flow cytometry to assess the immune cell profiles in the liver. Completion of these aims will yield
mechanistic insight linking mitochondrial and peroxisomal oxidation to spatial lipid deposition in the liver. The
proposed research reveals several innovative mechanisms that have yet to be explored, including how Cpt1a
alters PUFA oxidation and lipid droplet formation across the periportal-pericentral axis. In addition, the proposed
study uses innovative approaches including the use of zonal-specific gain- and loss-of-function mouse models
in conjunction with next generation spatial lipidomic and transcriptomic technology to address the overall
hypothesis. Strong collaborations among the University of Kentucky Arts and Sciences Imaging Center,
Oncogenomics Shared Resource Facility, COCVD Analytical research Core, Biostatistics and Bioinformatics
Shared Resource Facility, and the Center for Advanced Biomolecule Research at the University of Florida ensure
successful completion of the proposed research by the candidate. This R01 will support the applicant in reaching
his ultimate goal of becoming an independent yet collaborative, versatile PI leveraging his unique skill set in both
basic and clinical research arenas to identify novel therapeutics to treat cardiometabolic disease.

Public health relevance
PROJECT NARRATIVE Metabolic dysfunction-associated steatotic liver disease (MASLD) affects 1 billion people worldwide, and associates with a 4-year decrease in lifespan and greater cardiovascular disease risk. Impairments in the oxidation of long chain fatty acids have been associated with reductions in polyunsaturated fatty acids, microvesicular steatosis, and worsened liver injury. The primary goal of this proposal is to identify mechanisms explaining these associations, yielding further insight into novel therapeutic options for MASLD.